The Mechanisms of Profibrotic Sensitization by IL33

? DESCRIPTION (provided by applicant): Scleroderma lung disease (SLD), a combination of chronic pulmonary inflammation and unrelenting fibrosis, is the leading cause of death in patients with systemic sclerosis. Despite our increasing understanding of the mechanisms of SLD, better therapies are required. Transforming growth factor-ß (TGF-ß) stands out as the central profibrotic factor, including in SLD, but it is also the immunosuppressive and anti-inflammatory master regulator. Targeting TGF-ß might therefore provoke a robust proinflammatory host response. Avoiding this unwanted, potentially deleterious side effect is technically challenging. We propose a conceptually new paradigm based on a suggested mechanism that, if confirmed, would allow for targeting the profibrotic TGF-ß pathway in a way that minimally affects its basal anti-inflammatory and immunosuppressive action. We previously reported that fibroblasts obtained from patients with SLD and a related disease, idiopathic pulmonary fibrosis, display elevated expression of interleukin (IL)-33 mRNA and protein; similar elevations occur in the bleomycin model of fibrosis, and gene delivery of IL-33 potentiates the in vivo inflammatory and fibrotic host responses to bleomycin. In fibroblast culture, IL-33 strongly upregulates Smad2/3 phosphorylation, which appears to be independent of TGF-ß, because IL-33 delivery does not increase expression of TGF-ß, TGF-ß-activating, aV-containing integrins, or collagen mRNAs and proteins, and a blocking anti-TGF-ß antibody fails to attenuate the effect of IL-33 on Smad2/3 phosphorylation. Furthermore, when combined with TGF-ß stimulation of fibroblasts, IL-33 potentiates collagen biosynthesis to a far greater degree than would be anticipated for an additive effect. Thus, data suggest that IL-33 expression potentiates the profibrotic effect of TGF-ß but does not act through TGF-ß. We hypothesize that IL-33 potentiates the profibrotic effect of TGF-ß by inducing fibrosis-biased signaling, and the objective of this proposal is to investigate the corresponding molecular mechanisms. The following specific aims will address the mechanistic possibilities based on the known molecular processes controlled by IL-33 and TGF-ß: 1) Determine whether IL-33 potentiates profibrotic TGF-ß regulation by inducing intracellular signaling through its specific cell-surface receptor, T1/ST2, or, alternatively, through direct binding to the TGFBR and/or downstream intracellular signaling molecules; 2) Delineate the canonical and non-canonical TGF-ß signaling pathway components biased by IL-33 towards collagen production and expression of a spectrum of profibrotic cytokines; and 3) Establish whether global and/or fibroblast-specific deletion of IL-33 diminishes bleomycin- and TGF-ß-provoked tissue fibrosis in vivo. If the hypothesis of this investigation is validated, the results will form the basis for future molecular targeting of the I-33-TGF-ß fibrosis-biased pathway while sparing beneficial anti-inflammatory TGF-ß-driven regulation, leading to a conceptual shift in designing new therapies for fibrosis in SLD and other tissue fibroses.

Public health relevance
PUBLIC HEALTH RELEVANCE: Scleroderma is a serious disease, with so-called scleroderma lung disease (SLD) being the number one cause of death in these patients. The mechanisms of SLD are incompletely understood, and, as a result, existing therapies have limited efficacy. We previously discovered that the IL-33 molecule plays an important role in SLD and, together with the TGF-beta molecule, drives disease progression. By further elucidating the interplay between these cell signaling components, this research will chart a course for the development of better therapies for SLD and a broad spectrum of related diseases known as pulmonary and tissue fibroses.